Ethics of Emerging RCT Designs: Risk analysis and informed consent

1. Data collection in the PCORI sponsored study (PI: Andrew Vickers, Sloan-Kettering) of two stage consent for pragmatic trials has resumed after a hold due to the COVID crisis. A preliminary study's results was published in Clinical Trials. 2. I recently completed a review of the ethical issues in comparative effectiveness pragmatic trials. The analysis argues that unlike some approaches which attempt to erase the distinction between research and treatment, and thereby proposing a more relaxed regulation of pragmatic trials, I argue that a proper approach is to integrate both clinical ethics and research ethics. It is an argument against ethical exceptionalism. This has been published as an online chapter by Oxford U Press. 3. We are near end of writing a practical guide for IRBs in identifying the sources of research risks in pragmatic trials that compare already in use, standard treatments. These trials have been quite controversial despite their seeming lack of research risk. We are developing a practical guide grounded in rigorous ethical analysis that can help IRBs navigate this often confusing area. We anticipate submission for publication during this coming year. 4. With colleagues in Canada, I am part of a working group examining the ethics of pragmatic cluster RCTs for dialysis, with the aim of producing an overarching guidance document.